SULFUR AMINO ACID REQUIREMENTS IN YOUNG AND ELDERLY HUMANS

Study to examine the effect of intravenous glutathione on methionine, cysteine and leucine turnover utilizing stable isotope tracers of the respective amino acids.